A Phase 1 Study of Patient-Derived Multi-Tumor-Associated Antigen Specific T Cells (MT-601) Administered to Patients with Relapsed Non-Hodgkin Lymphoma

ABSTRACT
This application presents MT-601, a novel multi-tumor associated antigen (mTAA)-specific T cell product for the
treatment of Non-Hodgkin’s Lymphoma (NHL). NHL is the most common hematologic malignancy with ~80,550
new cases and >20,000 deaths in the US expected in 2023. Adoptive T cell transfer, e.g., CAR T cells, have
impressive potency in NHL yet are also associated with cytokine release syndrome (CRS) and neurotoxicity.
Additionally, relapse rates are up to 60% post-CAR T therapy due to low antigen levels or loss of CD19
expression. To date there are no approved therapies for NHL patients who relapsed after CAR T cell therapy,
resulting in a huge unmet medical need for alternate treatment options for NHL.
MT-601 represents a novel T cell-based immunotherapy that simultaneously targets 6 tumor-associated antigens
(TAA) (PRAME, NY-ESO1, survivin, MAGE-A4, SSX2, WT1) that are overexpressed in NHL but absent or with
limited expression in healthy tissue, thereby minimizing tumor escape and enhancing anti-tumor response.
Manufactured from autologous apheresis material, MT-601 recognizes target cells via native T cell receptors by
interacting with tumor antigen-expressing target cells presenting antigen in the context of both class I and II HLA,
leading to killing of tumor cells expressing any of these antigens and recruiting the patient’s immune system in
the anti-tumor response. Although other cellular immunotherapies attempt to address CD19 CAR T cell failures
by targeting 2-3 antigens, they are limited by 1) narrow epitope recognition, and 2) leaving the tumor susceptible
to relapse. In addition to broad-spectrum antigen targeting, MT-601 is the only cellular therapy being explored in
NHL patients who relapsed following CAR T therapy. Additional advantages of MT-601 include out-patient
administration and no genetic engineering. Furthermore, Marker’s multiTAA-specific technology was proven
clinically safe in >180 patients with various kinds of cancer. In a phase 1 trial of lymphoma patients using
multiTAA-specific T cells targeting 5 TAAs, patients had durable responses for much longer than those typically
associated with CAR T cells (6 years versus 28 months). Notably, Marker recently treated our first CAR T
cell relapsed NHL patient, who shows a complete response at 12 weeks post-infusion.
Based on this promising clinical data, Marker proposes a single-arm Phase 1 clinical study to advance MT-601
for patients with NHL that relapsed after third line CAR T treatment and do not have other approved therapy
options. The objective of Specific Aim 1 is to manufacture MT-601 and execute the clinical protocol by treating
NHL patients who have relapsed after CD19 CAR T cell therapy with MT-601. Specific Aim 2 will correlate
biological characteristics in the product profile with clinical safety and efficacy outcomes. Successful completion
of this grant will provide clinical proof of concept for MT-601 as a treatment for CAR relapsed NHL patients, and
support future clinical trials leading to future BLA filing and commercial approval of MT-601.

Public health relevance
Narrative This application will advance a novel therapy, whereby white blood cells are trained in the laboratory to recognize and kill cancer cells. These killer cells have the capacity to recognize multiple surface markers expressed by the tumor cells but not healthy cells. To date, more than 180 patients have been treated in clinical studies with this therapy with no serious side effects. This project will advance this innovative cellular therapy to treat patients with Non-Hodgkin’s Lymphoma (NHL), a malignant cancer of the lymph system, who relapsed following third line treatment and are left with minimal treatment options.